HIV Reservoir Ecology of Viral Remission (PTC)

PROJECT SUMMARY
Among the top priorities of the HIV field is the search for therapeutic interventions that can lead to sustained
antiretroviral therapy (ART)-free HIV remission. Although the majority of HIV-infected persons will experience
rapid viral rebound after ART interruption, there are rare individuals, termed post-treatment controllers (PTCs),
who demonstrate sustained virologic suppression for months or years after treatment cessation. These
individuals are considered an ideal example of durable HIV control, with direct implications for HIV cure
research. However, our understanding of the virologic determinants of HIV remission remains incomplete. This
is in part due to the scarcity of PTCs identified through any one research center or clinical trial, and in part
because of the limited scope of viral reservoir studies that have been performed to date. The main goal of this
proposal is to perform an in-depth virologic analysis of PTCs and our overarching hypotheses are that HIV
reservoir characteristics can provide mechanistic insights behind their ability to achieve HIV remission.
Through an international effort, we have established the Control of HIV after Antiretroviral Medication Pause
(CHAMP) study, the largest study of PTCs world-wide. Our initial studies of PTCs from the CHAMP cohort has
already yielded intriguing findings, including the identification of the first HIV reservoir biomarker, total proviral
genome numbers, that predicts which individuals will become PTCs after treatment interruption. While these
results are promising, the HIV reservoir is far more complex than just the total number of proviral genomes in
the peripheral blood mononuclear cells (PBMCs). The activity and impact of the HIV reservoir must take into
account a constellation of factors in a conceptual framework that we call the HIV reservoir ecology. This
paradigm incorporates the combined proviral, cellular and molecular circuits that contribute to HIV persistence,
including 1) the chromosomal environment of the HIV integration sites in the host genome, 2) susceptibility to
host immune responses, and 3) molecular pathways underlying viral persistence and reactivation. Until now,
technical challenges have hindered our ability to comprehensively characterize the HIV reservoir, but we have
overcome these technical hurdles with novel assays in our laboratories and propose to take a holistic approach
in characterizing the HIV reservoir ecology in both PTCs and NCs. The results of such studies will advance our
understanding of the mechanisms of HIV control in PTCs, with implications for predicting post-treatment control
and determining which of these circuits may be the best targets in the design of strategies for all individuals
living with HIV.

Public health relevance
PROJECT NARRATIVE HIV post-treatment controllers (PTCs) are individuals who can maintain virologic suppression after interruption of antiretroviral therapy and represent a natural model of sustained HIV remission. However, our understanding of the virologic determinants of HIV remission remains incomplete, which is in part due to the scarcity of PTCs identified through any one research center or clinical trial, and in part because of the limited scope of viral reservoir studies that have been performed to date. The main goal of this proposal is to perform an in-depth virologic analysis of PTCs and our overarching hypotheses are that a holistic and multi-omic evaluation of the HIV reservoir can provide mechanistic insights behind their ability to achieve HIV remission.